Aging and Metacognition in Strategic skill Acquisition

[unreadable] DESCRIPTION (provided by applicant): A critical issue regarding aging and cognition concerns the impact of strategic behavior as a cause of age differences in cognitive performance. Can the influence of strategies be identified in conjunction with the role of age-related changes in basic information processing mechanisms - such as a slowing in rates of associative learning or slowing in information processing speed? To what extent do age differences in strategic behavior in cognitive tasks produce, enhance, or reduce estimates of age changes in basic cognitive mechanisms taken from standard cognitive tasks? Although it is clear that age differences in cognitive strategies do not determine (i.e., completely account for) age differences in cognitive task performance (Light, 1996; Salthouse, 1991 ) they can play an important role in affecting age differences in performance on several classes of complex cognitive tasks (Dunlosky & Hertzog, 2001; Lemaire & Arnaud, 2002; Kausler, 1994; Rogers, Hertzog, & Fisk, 2000). The proposed research will clarify the influence of strategic factors on age differences in skill acquisition. We have adopted the noun-pair learning (NP) task (Ackerman & Woltz, 1994) to assess how quickly individuals switch from a slower form of controlled processing (visual search, or scanning, of an array to find target word pairs) to more fluent performance based on memory-retrieval (made possible by repeated exposure to the same pairings). Initial work with this task demonstrated that a substantial proportion of older adults do not rely on retrieval from memory to make rapid judgments in the NP task (Rogers & Gilbert, 1997; Rogers et al., 2000), opting instead to stay with the slower but effective strategy of scanning the array of possible answers. We have previously shown that both older and younger adults learn new associations and utilize this learning to guide skilled performance in the NP task (Touron & Hertzog, in press; Touron & Hertzog, 2003). A critical feature of our approach is collecting trial by trial strategy reports as well as online recognition memory probes, which allow us to track the way in which associative learning at the level of specific items leads to changes in strategic behavior for each person. Using this approach, we have shown that older adults are reluctant to rely on a memory retrieval strategy despite adequate noun-pair learning (item knowledge), and that this reluctance contributes to age differences in rates of skill acquisition. Persistent scanning behavior cannot be fully explained by deficient noun-pair learning - the shift toward retrieval is also influenced by age differences in strategy choice. A number of competing explanations for age differences in strategy choice are available, including: cognitive abilities, personality characteristics, metacognitive beliefs, performance monitoring, or the mental task model. The proposed research will consider these alternative mechanisms for and influences on older adults' retrieval reluctance. Our specific aims are to: (1) conduct an extensive individual differences study that evaluates the relationship of strategic choice to (a) background abilities, such as perceptual speed, associative memory, and fluid intelligence and (b) personal characteristics, including conservatism, conscientiousness, impulsivity, memory self-concept, and online monitoring of the accessibility of item knowledge; (2) assess age and individual differences in online metacognition, including differences in the experience of or access to a fast feeling-of-knowing as well as differences in updating of knowledge for latency differences across strategies.; (3) test the flexibility of initial response criteria and strategy preferences, by experimentally manipulating instructional sets, reward contingencies, and response deadlines; and (4) check the generality of these effects by extending to a separate skill acquisition task. Our goals are to demonstrate that older adults' skill acquisition behavior is governed both by age-related information processing constraints as well as by volition and strategic choice, to evaluate the role of that strategic behavior which impedes rates of learning in older adults can be overcome through intervention. [unreadable] [unreadable]